Cancer Immune Monitoring and Analysis Center

Summary
Because cancer immunotherapy constitutes one of the most transformative therapeutic movements over the
history of cancer treatment, there are now hundreds, if not thousands, of ongoing clinical trials in this field.
Despite the remarkable success for a subset of patients, there are substantial gaps in our knowledge. No more
than 30% of patients respond to immune checkpoint blockade and related therapies, many responding patients
develop therapeutic resistance, and many responding and non-responding patients suffer from immune-related
toxicities. There is a clear need to identify critical biomarkers of response, resistance, and toxicity. To improve
our ability to meet this challenge, the NCI-sponsored Cancer Immune Monitoring and Analysis Center (CIMAC)
program was created to enable consistent and comparable interrogation of patient biospecimens across multiple
clinical trials. The program has successfully established a common set of assays harmonized across the four
CIMACs, augmented this basic set with more specialized tests that may be CIMAC-specific but are still
accessible across institutions, deployed these tools across dozens of phase I/II immunotherapy trials, and
generated a pool of standardized data to facilitate inter-trial comparisons. The CIMAC created at Dana-Farber
Cancer Institute (DFCI) built on the existing Center of Immuno-Oncology (CIO) and the long-standing
collaboration with the Broad Institute of MIT and Harvard. The DFCI/Broad CIMAC, joining with the other
CIMACS, now proposes to continue the network mission to compare tumor and immune response features of
individual cancer types treated by multiple immunotherapeutic modalities and multiple cancer types treated by a
single immunotherapeutic modality in order to dissect common and individualized mechanisms of action. One
driving motivation for this renewal application is that the power to identify biomarkers increases with the number
of clinical trials analyzed. Thus, Aim 1 focuses on deploying the suite of assays established over the past five
years to biospecimens collected from additional innovative immunotherapy clinical trials to standardize biomarker
analysis and interpretation. To broaden the scope of parameters being examined, Aim 2 proposes to develop
and verify performance for novel and more complex assays to expand the network capabilities and advance
discovery. Of particular value will be methods that improve multiomic single cell profiling, multiomic spatial
analysis, and immunopeptidome characterization. Aim 3 addresses the challenge of integrating multiomic data
across an increasing number of clinical trials by building novel computational tools that can efficiently process
massive amounts of data and generate interpretable representations of the results. Altogether, these efforts will
support the role of immuno-oncology in the personalized treatment of cancer because only by the analyses of
large well-annotated datasets can we identify links between biology, molecular markers and clinical response.

Public health relevance
Narrative The creation of the Cancer Immune Monitoring and Analysis Center (CIMAC) program as part of the Cancer Moonshot Research Initiative established an unprecedented multi-institute network that delivers a more standardized analysis of biospecimens from immunotherapy clinical trials. The goal of this application is to not let this valuable resource go to waste but rather to continue the work by applying proven assays to a greater number of trials and by expanding the scope and sophistication of analysis with more comprehensive methods coupled with enhanced bioinformatic tools for facile data processing and improved biomarker identification. Our network will continue its mission to support, harmonize, compare, and disseminate existing and new approaches aimed at learning the mechanisms underlying responses to immune-based therapies for the treatment of cancer.